120 kV Transmission Electron Microscope for CU Anschutz Electron Microscopy Core Facility

Project Summary/Abstract:
We are requesting funds to purchase a Hitachi 7800 transmission electron microscope (TEM) for the Electron
Microscopy Core Facility (EMCF) at CU Anschutz Medical Campus in Denver (Aurora), Colorado. The EMCF,
managed by the Department of Cell and Developmental Biology, is a campus-wide, institutionally supported fee
for service facility that provides electron microscopy services for basic and clinical science investigators at CU
Anschutz as well as several investigators from neighboring institutions. Currently, the core has only one TEM, a
twenty-year-old Thermo Fisher Tecnai T12, which is no longer state of the art, is frequently out of service due to
failing components, is difficult to maintain and whose service contract will end December 2025. We need to
replace this aged TEM with a Hitachi 7800, which is also a 120 kV TEM, with a high contrast optic design ideal
for biological samples. The Hitachi 7800 has a proven robust hardware system and is especially designed for
easy and fast sample exchange. It has user-friendly software with unique features such as image rotation,
montaging, and pre-irradiation without the need to install secondary software. Acquisition of the new microscope
will greatly facilitate the health-related research of the laboratories listed in this application, as well as many other
laboratories who use the EMCF in support of their NIH funded research. Among other projects, the requested
microscope will be used to study important questions in diseases such as: early steps of HIV-1 infection,
Epidermolysis Bullosa disease, kidney disease, regulation of Staphylococcus aureus colonization and disease,
demyelination and remyelination, formation and function of meninges, and barriers to drug delivery.

Public health relevance
Project Narrative: Transmission electron microscopes are the most powerful microscopes, producing high resolution images at a resolution a thousand times higher than a light microscope, allowing study of intricate details within a cell. Changes in these sub-cellular features provide important clues to mechanisms of disease, dysfunction in aging, cancer, and genetic disorders.